ABNORMALITIES OF GONADAL/PUBERTAL DEVELOPMENT USING LHRH ANALOG

Assessment of efficacy and dosage of treatment of central precocious puberty with GnRH analogue, depot leuprolide acetate. Studies include effect upon pubertal development, adult height and bone mineral density.